Patient Oriented Research in Vulnerable Populations with Skin Disease

PROJECT SUMMARY/ ABSTRACT
This application proposes a renewal of a Mid-career Investigator Award in Patient-Oriented research for
Eleni Linos, MD DrPH, Professor of Dermatology at Stanford University. Dr. Linos’ long term career
objectives are to perform rigorous research to improve the care of vulnerable populations with skin
disease, including: a) the elderly, and b) racial and ethnic minorities. This renewed award will build on
her previous work and accomplish the following objectives: to expand her current research portfolio to
the care of vulnerable populations, and disease area of Hidradenitis Suppurativa.
The mentorship goals of this renewal proposal are aligned with the research aims. The proposed studies
provide hands-on research training experiences in quantitative and qualitative data collection and analysis for
mentees, and will produce preliminary data for mentees' K, T, and R applications.
The research aims will provide additional opportunities for mentees to develop skills in machine
learning, large language models, quantitative and qualitative research, biomedical ethics, health
disparities research and a new focus area of Hidradenitis Suppurativa. The new projects build directly on
her previous research and leverage existing networks, collaborations and access to leaders in behavioral
science and geriatrics, social media and technology.
Aim 1: To describe the progression of Hidradenitis Suppurativa using a longitudinal image library from patients
of diverse backgrounds and including all skin types.
Aim 2: To describe the mental health, sleep, and quality of life burden of Hidradenitis Suppurativa.
Aim 3: To identify barriers and solutions to the implementation of digital tools in the dermatologic care of
patients from racial and ethnic minority backgrounds.
This award will ensure that Dr. Linos has sufficient protected time to fully support her mentees,
particularly those from backgrounds historically underrepresented in medicine. The long-term goal of this
research is to expand knowledge on the care of vulnerable populations with skin disease, in order to
improve the quality of life and optimize dermatologic care of these patients. This K24 renewal award will
provide Dr. Linos with the opportunity to expand her mentoring and research on these topics and allow
her to train the next generation of dermatologic researchers so that they are equipped to improve the
lives of vulnerable populations.
Together, the Research Plan and Mentoring Plan provide a new five-year strategy that is directly
relevant to the NIH and NIAMS missions of training the next generation of physician scientists to carry
out patient-oriented research.

Public health relevance
PROJECT NARRATIVE The purpose of this proposed renewal of a K24 Midcareer Investigator Award is to mentor the next generation of patient-oriented researchers focused on improving the care of vulnerable populations with skin disease. The mentorship goals of this proposal are aligned with the research aims. We will use novel machine learning, quantitative and qualitative methods in order to highlight opportunities for improved care for two vulnerable groups of patients: a) the elderly and b) racial and ethnic minorities.